Cancer Education and Career Development Program

The disproportionate burden of cancer and other deleterious health disparities/inequities within minority and
underserved communities in the United States (US) is well-documented. A key barrier to achieving health equity
is understanding the multi-level determinants that lead to disparities, ranging from biological and genetic factors
to behavioral, environmental, and policy factors. Most health disparities associated with race/ethnicity and
socioeconomic status (SES) are complex and not determined solely by individual-level factors even though
cancer risk can be influenced by individual-level risk behaviors. The growing recognition of this complexity has
fostered innovative sociocultural, economic, behavioral, epidemiologic, and policy research that contributes to a
better understanding of disparate health outcomes. However, continued advances in the field depend on the
development of a diverse, appropriately trained scientific workforce. Our goal is to train a diverse cadre of
scientists with the skills and experience needed to address the range of challenges and opportunities in research
on cancer-related health disparities and to advance health equity policies at the national and local levels.
Enhancing multidisciplinary cancer health equity research will also contribute to the health of our nation by
expanding the research talent pool, enhancing innovation, and diversifying our health equity research leadership.
This renewal application is designed to continue to advance cancer health equity by providing a diverse cadre
of promising pre and postdoctoral trainees with the necessary education, mentored research training, and career
development opportunities to become productive independent researchers. We are submitting this application
for a competitive renewal of the Cancer Education and Career Development Program (CECDP) in response to
the T32 PA-16-152 since the R25T mechanism has been discontinued. The CECDP was initially funded in 1992
under the R25T mechanism, and we are seeking funding for Years 26-30. We propose the following specific
aims:
Specific Aim 1. To continue to provide an integrated educational experience combining a comprehensive
curriculum and a health disparities and leadership certificate program
Specific Aim 2. To continue to recruit a diverse group of pre and postdoctoral trainees who are dedicated
to a productive academic career in cancer, health disparities, and health equity.
Specific Aim 3. To prepare trainees to conduct independent research by providing strong interdisciplinary
mentorship and scientific specialization in cancer prevention and control
Specific Aim 4. To provide a solid foundation in the responsible conduct of research through formal
coursework and informal day-to-day activities related to scientific integrity.
Specific Aim 5. To employ an ongoing evaluation of program investments and program results so that the
T32 meets educational, mentored research training, and career development objectives.

Public health relevance
Project Narrative The purpose of the Cancer Education and Career Development Program (CECDP) at the University of Illinois at Chicago is to continue to train a diverse cadre of scientists with the skills and experience needed to become independent scientists and address the range of challenges and opportunities in research on cancer-related health disparities and to advance health equity policies at the national and local levels. We propose to continue this successful CECDP for years 26-30.